Duration of Hormonal Contraceptive Use: Immune Responses & Vaginal Microbiota

DESCRIPTION (provided by applicant): Over 300 million women worldwide use some form of hormonal contraception (HC). Animal studies suggest that effects of sex hormones on immune responses are dependent on the duration of exposure. Human studies have rarely focused on this issue. Our overall hypothesis for this proposal is that the duration of HC use is a critical independent factor that contributes to the effects of HC on mucosal immune responses and the vaginal microbiota. The aims of this proposal are: 1. To establish a prospective cohort of women initiating HC and follow these women for two years. 2. To determine the short-term and longer-term impact of HC use on the structure of the vaginal microbial communities. 3. To define the impact of short term and longer-term HC use on pro-and anti-inflammatory cytokine and chemokine responses in the vagina, ectocervix, and endocervix. The longer-term goal is to establish a specimen repository from this cohort that would allow us to further define changes in mucosal and systemic immune responses. This proposal is a collaboration between Johns Hopkins University School of Medicine, Johns Hopkins Bloomberg School of Public Health, and the University of Maryland Institute for Genome Sciences. The team assembled for this study encompasses the multidisciplinary expertise in metagenomics, statistics, immunology, epidemiology, infectious diseases, gynecology, and mathematical bioinformatics necessary to exploit the data that will be generated. There is no doubt that HC play an important role in maintaining health, as well as economic, and political stability. As such, their continued use is vital and incontrovertible. Understanding how the short-term and long-term use of exogenous sex steroids impacts immune responses and the lower genital environment is critical to ensure that these agents are used in a way that maximizes safety and efficacy. The information generated from this research program should help drive the development of diagnostic tools and identify new targets to improve women's health.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our overall hypothesis for this proposal is that the duration of hormonal contraception (HC) use is a critical independent factor that contributes to the effects of HC on mucosal immune responses and the vaginal microbiota. Over 300 million women worldwide use HC, so knowledge gained from identifying which women are likely to benefit from HC use and the type of HC that would provide the most benefit will help optimize the use of HC in women. Moreover, understanding how sex hormones influence immune responses would allow us to explore the possibility of harnessing these agents to maximize mucosal and systemic immune responses to vaccines.